Administrative Core

The Administrative Core will perform the centralized administrative functions for all 3 Research Components (Components 4-6) and the Pilot Projects (Component 7). It also will coordinate the activities of the Scientific Support Cores (Components 2-3). The Program Advisory Board will provide scientific oversight, and the Steering Committee will make executive decisions regarding ACTG activities. The Steering Committee will set goals, evaluate progress toward general scientific research directions, and oversee quality control mechanisms in all areas of Center activity. Oversight also will be provided for behavioral assays, production of viral vectors for gene silencing and transgenic expression, and imaging and histological analyses. The Administrative Core will also sponsor enrichment activities, including guest speakers, a course on the Neurobiology of Addiction for the UCSF Neuroscience Graduate Program, and an ACTG website to publicize ACTG-sponsored events, staff openings and links to other organizations’ websites. There will be two lines of administrative responsibility within the Administrative Core. Dr. Messing, the Center Director, will supervise the general coordination of all Center administrative activities and the Center’s budget. Dr. Ron, the Scientific Director, will supervise the coordination of and future planning for scientific directions

Public health relevance
The Administrative Core will manage all operations of the ACTG, oversee the research, manage the budget, ensure quality control, and promote opportunities for training and education, with the overall mission of ensuring progress toward accomplishing the scientific goals of the Center as a whole